Novel Neuroimaging and Neuropsychological Methods Sensitive to Cerebral Disruption in Veterans with Mild Traumatic Brain Injury

Identification of neuroimaging-based markers sensitive to mild neurotrauma and neuropsychological markers of
cognitive disruption is vital toward addressing the complex treatment needs of the large number of Veterans with
histories of mTBI. Although neuroimaging methods, particularly in the area of diffusion imaging (dMRI) continue
to show promise, there are significant limitations in the traditional, diffusion tensor imaging (DTI) based approach
in white matter (WM), where a high degree of heterogeneity of WM axon orientations and sampling from
disparate tissue types within a voxel contribute to inaccurate estimates of tissue properties. These limitations,
inherent in standard and widely used DTI methods, likely attenuate DTI sensitivity in the detection of mild forms
of neurotrauma, particularly in key, complex WM regions shown to be most susceptible to mTBI. Likewise,
cognitive research findings have been mixed, with conflicting reports and unclear cognitive outcomes that likely
cloud and confuse clinical decision-making. The heterogeneity of TBI, differences in injury characteristics, and a
non-uniform cognitive profile among affected Veterans likely contribute to the decreased sensitivity and
inconsistency shown across available studies that have typically leveraged traditional means-based
comparisons of neuropsychological test scores. Indeed, indicators of mTBI often fail to align with imaging findings,
as well the cognitive and functional outcomes reported by Veterans with histories of mTBI.
In the proposed study, we seek to apply new tools and methods in order to more sensitively examine WM
disruption and neuropsychological performance in 60 Veterans with mTBI and 60 Veterans without a history of
TBI. Participants will complete a broad neurocognitive assessment and will undergo an dMRI scan. We propose
that leveraging a novel neuroimaging approach—one that is robust to the limitations inherent in standard DTI
protocols—will enable investigation of WM proximal to the sulcal depths where all-cause mTBI is thought to inflict
the greatest damage given shearing effects in the gray-white matter border zone. We will use dMRI acquisition
and analysis methods which combine single and double pulsed field gradient dMRI acquisitions via a novel
technique called Joint Estimation Diffusion Imaging (JEDI) to integrate diffusion information at the voxel and
subvoxel level. Equilibrium probability (EP), an anisotropy measure that is more robust to the complexities of
crossing fibers and partial voluming effects, will be calculated using JEDI. In particular, we will interrogate EP of
voxels residing within the border between the gray and WM within frontal the sulcal depths. Simulation and
histopathological studies show these regions to be most susceptible to acute and distal effects of mild
neurotrauma given shearing effects that are particularly damaging because of differing tissue densities of the
gray-white border. Second, given our recent work showing the sensitivity of newer cognitive methods to detect
neuropsychological deficits in mTBI, we will investigate intra-individuation cognitive performance variability (IIV)
as a marker of cognitive disruption in order to enhance brain-behavior associations in Veterans compared to
traditional comparison of group means. Taken together, the proposed study presents an opportunity to
investigate white matter disruption within brain regions vulnerable to mTBI using a novel neuroimaging approach
(JEDI), further assess a promising cognitive concept (IIV) which may improve the evaluation of clinical outcomes
following mTBI, and examine potential associations between IIV and WM disruption in Veterans with mTBI. Such
cutting-edge work can lay the foundation for enhanced understanding of the neurobiological underpinnings of
mTBI and persisting postconcussive symptoms in Veterans with neurotrauma and may identify neuroimaging
biomarkers useful to evaluate treatment response in future trials.

Public health relevance
The proposed multidisciplinary project leverages state-of-the-art neuroimaging techniques alongside a promising method to characterize performance on neuropsychological tests in order to investigate the neurobiological underpinnings and cognitive effects of mild traumatic brain injury (mTBI) in Veterans. Our study incorporates novel diffusion neuroimaging methods that are sensitive to alterations in brain white matter (WM) in regions vulnerable to mTBI, and examines whether WM damage is related to non-uniformity of cognitive performances. This project will provide vital information regarding the presence of WM damage and associations with cognitive outcomes in Veterans with mTBI. Findings will help advance the care of VA patients by informing neuropsychological assessment approaches and helping elucidate the neural regions affected in mTBI, which may yield biomarker information useful in the evaluation of treatment response in future trials.